BEHAVIORAL AND HORMONAL RESPONSES TO STRESS IN INFANTS

Four groups of studies are proposed to examine the human infant's behavioral and physiological responses to stress. The focus of the work is on the pituitary-adreno-cortical system, a neuroendocrine system that plays a central role in stress-resistance. The goals of the research are 1) to characterize the infant's behavioral and adrenocortical responses to stimulation, particularly with role of novelty/uncertainty as primary psychological triggers of stress responses; 2) to examine infant and maternal characteristics that may influence that infant's psychobiological response to stressful events; 3) to begin to extend our analyses to consideration of Ill and Well premature infants who must cope with the stressors of illness and/or necessary NICU procedures; and 4) to develop paradigms to examine the relations between adrenocortical and a) brain evoked potentials b) activity of the immune system, and c) activity o the autonomic nervous system in human infants. Subjects will be male and female infants aged birth to 15 months. Ecologically relevant stressor will be examined in these studies, including: gavage feeding (premature infants), PKU blood-test, discharge exam, circumcision, (full-term newborns), inoculations, maternal separation, entering daycare, strangers, and novel experiences (infants 2 months and older). Activity of the adrenocortical system will be examined using measures of salivary cortisol. Observational techniques will be used to score behavioral state, coping strategies, and sensitivity/responsivity of caregiving. Collaborative efforts with other laboratories will be used to examine the linkages between adrenocortical activity and other stress-relevant systems as listed above. The proposed studies will provide basic data in the areas of psychobiology as such information pertains to child development and pediatric behavioral medicine. The long-term goals are to gain a better understanding of stress and coping in human infants.